Maximizing combination HIV prevention, uptake and retention by adolescent girls and young women

PROJECT SUMMARY
Our overarching goal is to arrest the HIV epidemic and its negative impact on young people in sub-Saharan
African (SSA) through improving the uptake, retention, and adherence of multi-level combination HIV
prevention by Adolescent Girls and Young Women and male partners. South Africa has an estimated 7.8
million people living with HIV. Despite having the largest HIV treatment program in the world, HIV incidence
in Adolescent Girls and Young Women (AGYW aged 15-24) remains high. Whilst there have been
significant innovations in HIV prevention, e.g., universal test and treat (UTT) and Pre-exposure
prophylaxis (PrEP), this has far outpaced the ability to deliver them. To control the HIV epidemic here is an
urgent to significantly improve uptake and retention of HIV care and prevention by AGYW and male
partners. In this project we had a unique opportunity to leverage time-sensitive events in a poor and rural
hyperendemic area of KwaZulu-Natal: The roll out of eight new youth-focused multi-level HIV prevention
interventions for AGYW and their male partners by PEPFAR’s Determined, Resilient, Empowered, AIDS free,
Mentored, and Safe (DREAMS) program in the context of a state of the art demographic and health
surveillance, where data on individual HIV biomarkers, sexual behaviors, HIV prevention and ART exposure
are linked to public-sector clinical records for HIV. We achieved this through three aims. Specific aim 1: We
quantified how multiple levels of social dynamics interact to predict uptake of DREAMS components. Specific
aim 2: We elucidated how individuals’ life-course and exposure to DREAMS affect retention and adherence to
HIV care and prevention. We found that: a) Despite high coverage, DREAMS did not accelerate decline in HIV
incidence. b) HIV incidence decline were explained by increases in men’s access to HIV treatment, although
barriers remain for young men. c) There is a high unmet sexual health need and self-testing, and self-sampling
were popular. d) Targeted Pre-Exposure prophylaxis (PrEP) didn’t reach AGYW most at risk, whilst peer-
navigators did. Specific aim 3: Ascertain whether family- and peer-network strategies improve uptake and
adherence to combination prevention interventions by young people. We worked with youth to interrogate the
findings and co-create an intervention. The result, Thetha Nami, (Talk to Me) consists of trained and
supervised peer-navigators who provide health promotion to young people; youth-friendly clinical services; and
peer-mentorship to improve retention in HIV prevention. We are currently testing the acceptability and
feasibility of this approach on improving adolescents and youth uptake and retention of HIV care and
prevention. Our multidisciplinary team includes HIV epidemiologists, a biostatistician, social
scientists, psychologist, and intervention development expertise in South Africa. Moving forward, this will
provide answers to: ‘Can peers and community-level interventions harness the full mortality and HIV incidence
reducing potential of HIV prevention for adolescents and young people in rural SSA?’

Public health relevance
PROJECT NARRATIVE Despite widespread availability of HIV testing, antiretroviral therapy, and effective biomedical HIV prevention such as HIV Pre-exposure prophylaxis, that can eliminate HIV acquisition and transmission, HIV incidence in adolescent girls and young women (AGYW) in South Africa is high. Leveraging a unique situation of complete surveillance data from Kwazulu-Natal in South Africa and DREAMS multi-level HIV prevention for AGYW, this study will provide evidence for interventions that can improve uptake and retention of AGYW and their male partners across multi-level combination HIV prevention and along the HIV treatment and prevention cascade. These findings will inform scale-up of HIV prevention and impact on the HIV epidemic and its negative consequences in communities in sub-Saharan Africa hardest hit by the epidemic.